Intraretinal stimulation for high acuity artificial vision

Prosthetic electrical stimulation of inner retinal neurons can restore a sense of vision in patients with outer retinal
degeneration, but implant patients to date report artificial vision to be low quality. Clinical studies of retinal
prostheses show that long-term implantation and stimulation is safe, and that implant patients can detect large
objects and recognize simple forms. But visual acuity is 20/438 at best, and functional vision is limited by rapid
(within seconds) fading of electrically elicited percepts. Numerous clinical and animal studies demonstrate that
current approaches for retinal stimulation cannot activate the retina with adequate spatial specificity to produce
high quality vision. Thus, the research team proposes to advance several innovative technical approaches that
will have the combined effect of substantially improving both spatial resolution and temporal control of evoked
responses. When implemented clinically, a retinal prosthesis incorporating the proposed technology is expected
to achieve 20/160 vision. Current retinal prostheses have numerous drawbacks. Epiretinal implants have planar
electrodes on the retinal surface, which often activate retinal ganglion cell (RGC) axons-of-passage.
Consequently, RGC axons with receptive fields far from the stimulation sites are unintentionally excited, resulting
in elongated percepts. Epiretinal electrodes tend to gradually separate from the retina, which also increases the
charge threshold. Suprachoroidal implants likewise have limited resolution due to the large currents needed to
bridge the distance across the choroid separating the electrode array and retina. Subretinal implants reduce the
electrode-retina distance and preferentially stimulate bipolar cells, avoiding RGC axons, thus achieving better
visual acuity than epiretinal implants. But photovoltaic subretinal implants that lack pulse timing circuitry use
simultaneous stimulation, resulting in overlapping electronic receptive fields and reduced spatial resolution.
Subretinal implants with extraocular cables can interleave stimulation to avoid simultaneous stimulation, but such
cables complicate surgery. In practice, subretinal implants can only be applied to a small part of the visual field
since implantation requires retinal detachment, thus limiting their effectiveness in treating retinitis pigmentosa,
which causes wide-field vision loss. The research team’s overarching hypothesis is that intraretinal electrodes
positioned within the inner nuclear layer can overcome all the above limitations. To test this hypothesis, the team
will define the mechanism of intraretinal stimulation by measuring RGC responses, optimize the
resolution of multichannel intraretinal stimulation using computational approaches to parameter
selection and tuning, and verify long-term functionality and biocompatibility of a high-density carbon
fiber array. With expertise in neural engineering, retinal neurobiology, and retinal surgery, the project team will
work collaboratively to design an innovative high-density retinal interface. The long-term impact of this project
will be artificial vision of higher fidelity that will improve the vision-related quality of life for people with retinitis
pigmentosa and age-related macular degeneration.

Public health relevance
Current retinal prostheses for treating blindness caused by photoreceptor degeneration lack the necessary spatial resolution to provide high acuity vision. Intraretinal stimulation achieved by ultrasmall carbon fiber electrodes can elicit responses from single retinal ganglion cells without inadvertently activating nearby axons. The project will investigate basic mechanisms of intraretinal stimulation, optimize stimulation parameters, and assess functionality and biocompatiblity of an intraretinal stimulation array in a large-eye animal model.